Investigator Development Core

PROJECT SUMMARY – Investigator Development Core
The RCMI@Morgan has established an Investigator Development Core (IDC) that focuses on providing junior-
level faculty and postdoctoral fellow investigators with the research resources and training needed to catalyze
the scientific growth and professional development of early-stage investigators (ESI) and facilitate their transition
to independent biomedical researchers. The IDC will implement strategic initiatives including an effective Pilot
Project Program, a Summer Research Partnership Program, hands-on grant writing workshops, grant and
manuscript writing support, and a variety of activities to help network investigators with multi-disciplinary
professional communities and mentors. The proposed activities are widely recognized as the best practices in
research infrastructure enhancement and ESI career development. An innovative aspect of our approach is to
foster interdisciplinary conversation and collaboration between social/behavioral scientists and basic biomedical
science researchers in STEM disciplines as well as translational researchers. Our aims are designed to equip
Morgan State’s investigators with what they need to become successful, technology transfer-minded, funded,
and productive biomedical and behavioral health investigators who will advance their research careers in areas
related to minority heath and health disparities. Our Aims are 1. To administer an effective Pilot Project Program
designed to jump start research projects including potential technology transfer projects that will result in
externally funded research grants (K Series, SuRE, R21, R01, etc.) As such, the IDC will continue to promote
and implement our program for soliciting, receiving, reviewing, and funding pilot grant proposals that focus on
research related to diseases and conditions that disproportionately impact minority and under-represented
populations. 2. To build on our infrastructure to support investigators’ efforts to establish robust academic
research careers, with special emphasis on ESI. Under this Aim, the IDC will administer hands-on grant writing
workshops for new investigators and investigators new to NIH research, provide early-stage investigators with a
structured mentoring relationship, including post-review support, to help them build their networks of colleagues
and research collaborators, support a Summer Research Partnership Program with faculty at research-intensive
regional institutions, and continue to network with MSU’s Office of Research Administration to help devise
protocols and procedures to facilitate the grant and patent submission process at MSU. 3. To build on and
maintain “Communities of Research” for biomedical and behavioral health researchers at MSU and with partner
institutions. The IDC will foster interdisciplinary collaborations among MSU investigators as well as collaborations
with investigators at research-partner institutions, including other RCMI institutions, through health disparities
colloquia and mixers, annual health disparities mini-symposia and conferences, and conduct interdisciplinary
scientific writing accountability groups (SWAGs) to support investigators’ efforts to develop peer-reviewed
articles that are published in high-impact journals.